THE NON-GMP SYNTHESIS OF 100 GRAMS OF (R)-N-(6-CHLORO-4-((1-PHENYLETHYL)AMINO)PYRIDO[3,4-D]PYRIMIDIN-5-YL)METHANE-SULFONAMIDE (MTX-531)

THE NON-GMP SYNTHESIS OF 100 GRAMS OF (R)-N-(6-CHLORO-4-((1-PHENYLETHYL)AMINO)PYRIDO[3,4-D]PYRIMIDIN-5-YL)METHANE-SULFONAMIDE (MTX-531)